New York Regional Center for Diabetes Translation Research

Behavioral Science and Technology Core
The Behavioral Science and Technology Core (BSTC) of the New York Center for Diabetes Translation
Research will provide consultative services and technical support to high-quality translational intervention
research that targets diabetes-related health behaviors, using rigorous methods that are informed by multi-
stakeholder input and collaboration. Innovatively, BSTC now includes faculty expertise in clinical diabetes and
landmark clinical diabetes intervention trials, leveraging a strong link to the NIDDK-funded Einstein-Mount
Sinai Diabetes Center. An additional novel BSTC service builds on strengths of our first funding period to
promote the use of cutting-edge technologies to measure behavior as it occurs in real-time and in the context
of a naturalistic environment, and to deliver mobile health (mHealth) applications and just-in-time interventions.
The BSTC brings together a rich set of resources to support translational investigators working to overcome
barriers to widespread dissemination and implementation of evidence-based strategies that target clinical
management and/or behavior and lifestyle change to reduce diabetes health disparities in real-world health
care and community settings. BSTC specific aims are: 1) To support and promote diabetes translation
research, grounded in state-of-the-art behavioral science and clinical diabetes, tailored to maximize impact on
diabetes health equity. Consultation services support use of cutting-edge behavioral science and clinical
diabetes knowledge to refine hypotheses about mechanisms and moderators of intervention effects and guide
evaluation plans. 2) To facilitate stakeholder informed and community-engaged translational research methods
for maximal real-world impact. Consultation services address community-based participant research and
stakeholder engagement methods, providing access to an innovative and highly experienced Diabetes
Accelerator, a diabetes translation research focused stakeholder group from diverse backgrounds. 3) To
consult on and provide access to innovative mobile health technologies to deliver interventions, tailoring
interventions to the needs of individuals at particular moments in time, and measure outcomes. Consultation
services address: selecting appropriate technologies, incorporating them into tailored interventions, and using
these to reach individuals living with or at risk for diabetes in their natural environments. 4) To facilitate
application of rigorous evaluation methods that can advance behavioral science and evidence-based practice.
Consultation services address: selecting outcome measures with sound measurement properties,
implementing quality control and fidelity assessments, applying advanced statistical, qualitative and mixed-
methods in comprehensive assessments of program effectiveness [e.g., reach, effectiveness, adoption,
implementation and maintenance (RE-AIM)].
.